Children's Allergy and Asthma Data Repository (CADRE)

PROJECT SUMMARY
Identifying modifiable prenatal and early life risk factors is crucial for developing strategies to prevent childhood
asthma. While individual birth cohort studies have identified several asthma-related genetic, personal and
environmental risk factors, these studies were mainly limited to homogeneous cohorts and modest sample sizes.
Pooling data from multiple diverse cohorts could address these limitations. Based on the momentum and
accomplishments of collaborative multicenter research in the Children’s Respiratory and Environmental
Workgroup (CREW), we propose establishing a children's allergy and asthma data hub to ensure enduring
access for the scientific community to allergy and asthma birth cohort data. The proposed Children's Allergy and
Asthma Data Repository (CADRE) will leverage hundreds of millions of NIH dollars invested in conducting allergy
and asthma cohort studies by pooling and harmonizing these data for future collaborative studies. We propose
to initiate CADRE using CREW’s existing data set and data-sharing procedures and then expand this critical
resource to invite, facilitate and accommodate broad participation from the scientific community. The CADRE
data repository will invite collaboration and ensure ease of use by providing value-added services to facilitate
data accessibility, usability, harmonization and interpretation. To accomplish these goals, we propose three
specific aims. First, we will expand the CREW repository of birth and infant cohorts’ data focused on identifying
risk factors, clinical phenotypes and natural history of childhood allergic diseases and asthma by collecting more
data from the original cohorts and by recruiting new collaborators and cohorts to contribute data to the repository.
Second, we will develop the CADRE data collaboration platform as a foundation for a national data ecosystem
for secure integrative allergic diseases and asthma research. Third, we will establish the administrative
infrastructure to develop, refine and establish an ethical and compliant data-sharing and governance process for
the acquisition, linkage, usage, and analysis of multidimensional data containing protected health information
(PHI) and secure export non-PHI results to investigative teams. Establishing the CADRE data repository will
preserve, pool, and harmonize the precious and far-reaching data sets of US childhood asthma and allergy
cohorts. CADRE will develop secure procedures to facilitate investigators' access and utilization of these
comprehensive and irreplaceable data for collaborative studies while simultaneously protecting the privacy of
research participants.

Public health relevance
PROJECT NARRATIVE Identifying modifiable prenatal and early life risk factors is crucial for developing strategies to prevent childhood asthma. While individual birth cohort studies have identified several asthma-related genetic, personal and environmental risk factors, these studies were mainly limited to homogeneous cohorts and modest sample sizes. We propose establishing a children's allergy and asthma data hub (The Children's Allergy and Asthma Data Repository, or “CADRE”) to ensure enduring access for the scientific community to allergy and asthma birth cohort data.